Determining network signatures of pharmacoresistance in focal cortical dysplasia-related epilepsy

Focal cortical dysplasia (FCD) is the most common cause of surgically-remediable, pharmacoresistant
epilepsy in children. FCD-related epilepsy often starts at a young age, placing children at risk of neurocognitive
impairment and exposure to the side effects of antiseizure medications. Despite the regularity of FCDs, these
lesions are often subtle which can lead to delays in detection; and even after detection, there are often long
delays to epilepsy surgery. Current structural imaging and FCD pathological characteristics have failed to
identify consistently those children at risk of developing pharmacoresistant epilepsy, and who would benefit
from surgical intervention. Recent evidence has implicated that these focal lesions can cause widespread
disruptions of distributed brain functional networks.
Resting-state functional magnetic resonance imaging (rs-fMRI) is a validated, noninvasive imaging
method that can identify stable functional networks across pediatric and adult subjects. Using advanced
processing and statistical methods, these networks can be studied and compared quantitatively at the
individual and group levels.
This proposal tests the overall hypothesis that FCD-related epilepsy disrupts established cortical
networks, and that the quantity and location of these perturbations determine which patients develop
pharmacoresistant epilepsy. The aims of this research plan will identify 1) quantitative local, regional and
remote network connectivity alterations and 2) network hub reorganizations associated with
pharmacoresistance. This information will alter clinical practice by characterizing functional network markers of
pharmacoresistance, allowing earlier identification and utilization of epilepsy surgery as guided by the 2021
NINDS Epilepsy Research benchmarks (IIA,C,IIIC). Nathan T. Cohen, MD (PI) is a board-certified pediatric
epileptologist with clinical and research experience in advanced imaging of epilepsy. The proposed training
plan will allow him to develop expertise in functional connectivity analysis, to master applied biostatistics, and
to learn prospective and multicenter trial design. The candidate has organized a targeted mentorship team
including William D. Gaillard, MD, and Chandan J. Vaidya, PhD whose expertise in functional imaging of
pediatric epilepsy will allow him to achieve these goals. This K23 Career Development award will allow Dr.
Cohen to transition to a line of independent investigation using functional imaging techniques to study the
underpinnings of pharmacoresistance and the neurocognitive, behavioral, and psychiatric comorbidities of the
epilepsies.

Public health relevance
Focal cortical dysplasia (FCD) is the most common cause of surgically-remediable, pharmacoresistant epilepsy in children, yet based on current imaging and clinical characteristics it is not possible to predict which children will develop pharmacoresistance, and which patients may have a more benign course of drug- responsive epilepsy. There is evidence that FCD epileptic activity can impact and alter distributed cortical functional networks, and this study uses functional imaging techniques to define network alterations as a marker of pharmacoresistance. The results of this proposal will allow clinicians to identify earlier those FCD patients who will benefit from surgical resection, sparing them the years of burden of ongoing seizures and cognitive, developmental and economic impact of chronic antiseizure medication therapy.